Stanford Clinician Scientist Training Program

Basic science, translational, and clinical research in Otolaryngology – Head and Neck Surgery
is improving the way we diagnose and treat patients. A critical component of these research
areas is the partnership among clinicians, clinician-scientists, and basic scientists. Herein, we
propose to enhance a research training program designed to cultivate clinician-scientists who
are interested in studying hearing, balance, taste, smell, voice, speech, and language. Our
research training program is designed to provide residents and medical students with intense
research experiences, a structured didactic program, and close mentorship and guidance.
Trainees will be ingrained with the philosophy that research is collaborative between MD and
PhD scientists. Our short-term goals are to recruit and train diverse and promising scientists
studying communication health and diseases, who will make and share innovative discoveries.
The ultimate long-term goal of our training program is two-fold: our graduates will 1) become
independent NIH-funded investigators in faculty positions in academic departments, and 2)
improve human health by advancing our field via scientific discovery that is translated to clinical
care.

Public health relevance
Research is advancing the field of Otolaryngology–Head and Neck Surgery. Here, we have designed a research training program to train the next generation of physician-scientists in areas aligned with NIDCD missions, to ultimately improve human health by combining scientific discovery with clinical care.